Telomerase Reverse Transcriptase in Vascular Homeostasis

The vascular endothelium plays an essential role in coordinating diverse circulatory
functions such as blood flow, thrombosis, leukocyte trafficking, and even metabolism. Normal
endothelial function is characterized by a quiescent cell phenotype that is non-proliferative,
non-migratory, and exhibits a cell surface that prevents thrombosis, inflammation, and lipid
deposition, thereby resisting atherosclerosis and vascular disease. A key stabilizing
stimulus for endothelial quiescence is laminar fluid shear stress (FSS) on the cell
surface that is a feature of straight vascular segments. In contrast, curved and
branching arteries experience chaotic FSS, called disturbed flow, that dictates a less
stable, activated, endothelial phenotype that is more susceptible to atherosclerosis. The
mechanisms governing endothelial phenotype in response to fluid shear stress are
incompletely understood. In this application, we present data that peroxisome proliferator
gamma coactivator-1α (PGC1α), is a fluid shear stress-responsive factor in endothelium that is
upregulated with laminar, but not oscillatory FSS. Upregulation of PGC1α is important for the
activation of key pathways linked to normal vascular homeostasis such as Klf2, Notch, and
eNOS that promote a stable anti-atherosclerotic endothelial phenotype. Exciting pilot data
links this effect to upregulation of telomerase reverse transcriptase (TERT) and its
extra-nuclear, telomere length-independent, function to stabilize maintain
mitochondrial homeostasis in response to laminar FSS. Endothelium lacking TERT activity
shows mitochondrial fragmentation and fails to align with flow, a key function needed
to resist atherosclerosis. Collectively, these data prompt our central hypothesis that
endothelial PGC1α-TERT signaling is required for endothelial and vascular adaptation to
shear and normal vascular homeostasis. To investigate this hypothesis, we propose to first
determine how PGC1α influences endothelial responses to FSS in vivo using a
tamoxifen-inducible Cre/Lox system producing endothelial specific PGC1α-gene excision, in
situ confocal microscopy, single-cell RNA-seq, Network Medicine, and the ApoE-/- atherosclerosis
model. Similarly, we will use the same strategy with inducible endothelial TERT gene excision.
Finally, using cell culture of cells lacking either PGC1α or TERT, we will dissect the
mechanisms whereby PGC1α-TERT signaling impacts endothelial FSS responsiveness with a
particular focus on FSS-induced PGC1α genome occupancy, mitochondrial and cellular metabolism,
endothelial cell flow alignment, and TERT localization to the nucleus vs. mitochondria.
Collectively, these studies will provide insight into a new paradigm of endothelial cell
responsiveness to FSS and the requirements to maintain a quiescent endothelial monolayer that
resists vascular disease. With this information, we should have the requisite insight to design new
therapies to alleviate morbidity and mortality from vascular disease.

Public health relevance
This project will investigate how the blood vessel lining, known as the endothelium, is responsive to the amount of blood flow in one's vessels. We have found that genes that influence mitochondria, the cellular energy producers, also have an important role in controlling blood vessels. The work from this proposal will help provide knowledge needed to design treatments that will improve blood vessel function and prevent vascular disease.